Optical Genome Mapping As a Novel Diagnostic Approach in Pediatric Brain Tumors

ABSTRACT
One of the greatest advances in pediatric brain tumor management has been the incorporation of tumor
molecular findings in the diagnosis, prognostic stratification, and treatment of patients. Because of this, treatment
options and outcomes for patients with specific alterations, including structural variants (SVs) resulting in fusions,
have greatly improved. However, despite multiple research studies that show SVs are important for tumor
development, maintenance, and progression, clinical analyses are generally limited to targeted gene sequencing
panels (DNA +/- RNA) and targeted fluorescent in situ hybridization (FISH). This type of testing is sufficient for
brain tumors that harbor classic genomic alterations, but inadequate for tumors that have atypical histological or
molecular aberrations, oftentimes resulting in “negative” genomic testing. In addition, some of these tests have
a long turnaround time, leading to delays in diagnosis and treatment. We are in great need for a clinical test that
will allow for more accurate and rapid discovery of clinically significant SVs that can be used along with
sequencing to create treatment plans with maximum benefit. Optical Genome Mapping (OGM) is a promising
genomic technology that can help fill this molecular diagnostic gap. Our preliminary data utilizing about 60
pediatric brain tumor samples demonstrates the utility of OGM to identify previously known diagnostic SVs (i.e.,
BRAF-fusion), cryptic SVs that were not identified by clinical tests, and novel SVs that have never been described
in pediatric brain tumors. Although novel in the field of pediatric brain tumors, OGM is being used clinically as a
CLIA/CAP certified diagnostic test for Facioscapulohumeral Muscular Dystrophy (FSHD), a disorder that
previously required southern blotting for diagnosis. More recently, the Augusta University Pathology Department
submitted a successful Laboratory Developed Test application for OGM as a diagnostic test for hematologic
malignancies to the American Medical Association. We propose to implement optical genome mapping (OGM)
as a first line diagnostic approach for pediatric brain tumors in a clinical setting and utilize OGM to discover
genomic SVs with potential clinical relevance. This study will be the first to generate pre-clinical evidence that
brain tumor-driving genetic alterations can be rapidly identified using OGM, with the potential to guide clinical
treatment plans for children with these tumors. By the end of the study period, OGM will be validated in CLIA/CAP
certified laboratories (Children’s National Hospital Pathology, Bionano Laboratories, Augusta University), and a
laboratory developed test application submitted pending promising results. This study will also utilize OGM for
the discovery of novel pathogenic SVs in a large cohort of pediatric brain tumors samples, which may be used
to improve diagnosis, allow for better outcome prediction, and ultimately advance therapies for affected children
with brain tumors. The results of this study will have a direct impact on clinical care without requiring a clinical
trial. Although this study will primarily focus on pediatric brain tumors, OGM can also be applied to other tumor
types, expanding the therapeutic possibilities for children and adults diagnosed with these cancers.

Public health relevance
Project Narrative Although numerous large studies have been done to demonstrate that structural variants (SVs) are important for brain tumor diagnosis and management, the full spectrum of SVs within pediatric brain tumors is not fully characterized and a clinical test that can rapidly and accurately identify all clinically relevant SVs is absent. In this study, we will work with Augusta University and Bionano Laboratories to validate and develop optical genome mapping, a method that uses ultra-high molecular weight DNA to identify SVs, as a clinical test for pediatric brain tumors and concurrently discover novel SVs in a large cohort of 1000 brain tumor samples. The outcomes of this study will provide a pathway for discovery of novel SVs, as well as allow for improved diagnostic, prognostic, and therapeutic management of brain tumors in children.